Timing Of Exercise In Concussed Rat Athletes

Project Summary/Abstract
Repeat concussions are a growing concern for adolescents and young adult athletes. Experimentally
one of the problems is that no one has been addressing this in an “athlete” model. Growing evidence
shows that the brains of those that exercise regularly (athletes) are very different than those that are
sedentary. These differences will affect how the “athlete brain” responds to concussive injuries. In this
application we have developed a rathlete model to study the effects of concussive injuries and recovery
between the athlete brain and non-athlete brain in both male and female rats. This work will not only
provide important information regarding brain injury research, but emphasize the role of exercise in
adolescent health.

Public health relevance
Project Narrative Repeat concussions are a growing concern for adolescents and young adult athletes, but current experimental research does not include an “athlete” model when assessing responses to concussions. In this application a rat athlete model is used to study the concussive recovery between males and female “rathletes” and determine when is the optimal time to resume physical activity after concussive injuries. This work will not only provide important information regarding brain injury research, but emphasize the role of exercise in adolescent health.